Stroke Prevention in Nigeria: SPRING 2

SUMMARY:
We propose a multicenter open-label, single-arm type I hybrid trial to assess the effectiveness of hydroxyurea
therapy for primary stroke prevention in children with sickle cell anemia (SCA) living in Nigeria. Our team just
completed a double-blind, parallel-group phase III randomized controlled trial (SPRING), where we compared
low-dose to moderate-dose hydroxyurea for primary stroke prevention in children with SCA and abnormal
transcranial Doppler (TCD) velocities (>200 cm/sec). Children with abnormal TCD velocities have a high stroke
risk of approximately 10.7 events per 100 person-years (observation arm in the STOP trial). In the low- (n=109)
and moderate-dose (n=111) hydroxyurea groups, the stroke incidence rates were 1.2 and 1.9 per 100 person-
years, respectively, p=0.77 (combined incidence rate 1.5 per 100 person-year). Despite equal efficacy for
stroke prevention in both treatment groups, moderate- when compared to low-dose hydroxyurea, was more
effective in preventing severe acute pain and all-cause hospitalizations. Our findings supported the American
Society of Hematology's evidence-based guidelines for hydroxyurea therapy for primary stroke prevention in
low-income settings. Our hypothesis to be tested: in a multicenter single-arm type I hybrid trial, for children with
abnormal TCD velocities treated with hydroxyurea, the stroke incidence rate will be non-inferior to the SPRING
trial results, with an upper non-inferiority margin of 4 strokes per 100-person-years. The point estimate method
was used to determine the non-inferiority margin based on the Nigerian pediatrician's judgment of what
maximum stroke rate would be clinically meaningful to demonstrate the effectiveness and justify treatment for
the high-risk stroke group. A non-inferiority test with an overall sample size of 220 participants will achieve 91%
power at a 0.050 significance level to detect non-inferiority when the expected proportion of strokes is 0.035, a
minimum follow-up period of 2.5 years and a loss to follow-up of 10% per year. Participants will be followed as
per standard care, including clinic visits every 3 months and complete blood cell counts every 6 months. We
will conduct the following aims:1) Determine the incidence of the first stroke and TIA in children with abnormal
TCD velocities treated with hydroxyurea for 2.5 years in the type 1 hybrid trial; 2) Evaluate the implementation
and sustainability of the intervention within the extended RE-AIM framework; 3) Evaluate the cost-effectiveness
of low- compared to a higher dose of hydroxyurea for primary stroke prevention in children with abnormal TCD
velocities. Capacity building for the three Nigerian Multiple Principal Investigators, the statisticians, and nurses
will be focused on three areas- a) developing a Nigerian data coordinating center and the required skills to
support a clinical trial; b) developing a regional TCD course for nurses, enhancing task shifting and reach, and
c) performing cost-effective analysis for the type I hybrid trial comparing low-and moderate dose hydroxyurea.

Public health relevance
PROJECT NARRATIVE: In 2020, our research team completed a multicenter phase III randomized controlled trial for primary stroke prevention in children with sickle anemia, demonstrating that children with an annual 10% stroke risk because of a high velocity of blood flow in their brain could be treated with either low or moderate dose hydroxyurea for a significant decrease in strokes. We propose an open-label, single-arm, type I hybrid trial (phase IV trial) for primary stroke prevention initially with low-dose hydroxyurea and subsequently with moderate-dose hydroxyurea based after at least two severe pain events requiring physician contacts during the trial and assessment of ways to maintain the sustainability of stroke prevention programs. We will conduct a cost- effective analysis to determine the sustainability, relative cost, and effectiveness of the hydroxyurea dose on stroke prevention and healthcare utilization.